Massachusetts Alzheimer's Disease Research Center P30 Diversity Supplement Gaona

Project summary:
The Massachusetts Alzheimer’s Disease Research Center requests a diversity supplement to
support hiring a Mexican American post-baccalaureate student in their Neuropathology Core.
The student requests support to provide scientific training and mentoring to enhance her
goal of attending graduate school, with the plan to obtain a PhD in Neuroscience. The
planned experiences include training in neuroanatomy, neurohistology, advanced imaging
methods, neuropathology, tissue preparation techniques, and neuronal cell culture. These
experiences are within the scope of the funded MADRC Neuropathology core. The candidate
will be mentored scientifically and for career growth by a mentoring team of Dr Matthew
Frosch, Director of the Neuropathology Core, Dr Hyman, Director of the Center, Dr Oakley, a
junior faculty neuropathologist, and two members of the faculty who may be able to provide
examples of successful role models as well as mentoring and support – Dr Teresa Gomez Isla
and Dr Liliana Gomez Ramirez, both members of the MADRC team.

Public health relevance
Narrative: The Massachusetts Alzheimer’s Disease Research Center requests a diversity supplement to support hiring a Mexican American post-baccalaureate student in their Neuropathology Core. The student requests support to provide scientific training and mentoring to enhance her goal of attending graduate school, with the plan to obtain a PhD in Neuroscience. f